Resonant Voice Index: Developing an Objective Acoustic Model to Quantify Forward-Focused Vocal Resonance

PROJECT SUMMARY
This project aims to develop the Resonant Voice Index (RVI), an objective tool for assessing vocal
resonance in clinical voice evaluation. Voice quality depends on the interaction between vocal fold vibrations
(source) and the vocal tract (filter). When optimally coupled, this interaction creates forward-focused
resonance, a resonant voice quality characterized by clear tone, minimal effort, and efficient use of the
resonators. Current clinical practice relies only on subjective perceptual ratings that lack reliability and
sensitivity.
The RVI will be a multiparametric model incorporating acoustic features that quantify forward-focused
resonance, offering clinicians an objective measure that matches the complexity of expert perceptual rating.
The project has three aims:
1. Determine causal relationships between acoustic features and resonance perception: Use
speech resynthesis of standard voice evaluation stimuli to systematically manipulate selective acoustic
features and determine their specific impact on perceptual ratings of resonance.
2. Validate acoustic predictors of resonance through natural voice analysis: Examine a diverse
corpus of natural voice recordings to identify which acoustic features consistently correlate with expert
perceptual ratings of resonance. This will confirm which features identified in Aim 1 generalize to real-
world voice samples across speakers.
3. Develop the Resonant Voice Index: Apply machine learning techniques to integrate validated
acoustic features into comprehensive, clinically applicable indices that objectively quantify resonance
quality.
The RVI addresses a critical gap in clinical voice care by providing clinicians with an objective tool for
reliable and sensitive evaluation, clinical decision making, and tracking of resonance-related outcomes. Due to
the popularity of resonance-focused treatment (e.g., resonant voice therapy, semi-occluded vocal tract
exercises, Vocal Function Exercises), the RVI can benefit millions of patients. This research directly supports
the NIDCD's strategic goal of improving evaluation and treatment of voice disorders to enhance the quality of
life for these patients.

Public health relevance
PROJECT NARRATIVE This project will develop the Resonant Voice Index (RVI), a multiparametric model that combines acoustic features to objectively measure the degree of resonant voice. The RVI will improve the diagnostic accuracy and treatment monitoring of voice disorders. By providing a reliable and sensitive method for assessing resonance, this tool will enhance clinical voice care and treatment outcomes.